Osteoarthritis Progression And Sensory Pathway Alterations

The overarching aim of this project has been to characterize the sensory innervation of the knee, in order to
explain its role in painful knee osteoarthritis (OA). We have identified two fundamental processes underlying OA
pain: (1) mechanical sensitization and (2) anatomical neuroplasticity of joint nociceptors. In the course of
experimental OA, joint nociceptors become sensitized to mechanical stimuli, manifest as knee hyperalgesia
(early disease) and weightbearing asymmetry (late). Concurrently, remodeling of joint innervation occurs, with
sprouting of nociceptors into the synovium and the subchondral bone (SCB). Using transcriptomic data, we have
generated compelling evidence that a specific subset of nociceptors, nonpeptidergic NP1, is absent from healthy
joints but sprouts into the SCB of OA joints and mediates weightbearing pain. This NP1 subset is molecularly
defined by druggable receptors, including the Mas related G-protein coupled receptor d (Mrgprd). MrgprD+ fibers
have been shown to be mechanosensitive and hyperexcitable. Our pilot data indicate that Mrgprd knock out mice
are protected from weightbearing deficits and sprouting after DMM. We aim to test the hypothesis that NP1 fibers
represent a subset of nociceptors that can be targeted for OA pain. In Aim 1, we will establish the pattern of
innervation by NP1 fibers in murine and human knees. We will document their spatio-temporal neuroplasticity in
murine knees of both sexes (PMX, primary OA), and validate findings in human knee tissues from postmortem
donors and total knee arthroplasty. We will also profile NP1 neurons in murine and human DRGs. In Aim 2, we
will examine the effects of agents that can reverse the hyperexcitability and sprouting of NP1 neurons, focusing
on Mrgprd inverse agonists and other drug candidates. Aim 2A will examine effects on excitability, using (1)
electrophysiological recordings from optogenetically identified Mrgprd+ neurons, (2) excitation of Mrgprd-
GCaMP6 neurons driven by knee manipulation, and (3) OA pain. Aim 2B will investigate the effects of these
agents on sprouting of murine Mrgprd-eGFP or human iPSC-derived neurons, using microchips to assess axon
growth. We will examine whether agents that reduce the excitability of these neurons also impact their sprouting.
Aim 3 will examine the consequences of chronic inhibition of Mrgprd signaling using Mrgprd ko mice. We will
perform PMX or sham surgery in mice and monitor them for pain-related behaviors, DRG molecular profiles, joint
innervation, and joint integrity. We will also use Mrgprd ko x Pirt-GCaMP3 mice to perform in vivo Ca2+ imaging
of DRG in order to assess the functional responses to mechanical stimuli as a result of decreased sprouting.

Public health relevance
We aim to test the hypothesis that a subset of nonpeptidergic nociceptors, the NP1 subset, mediates weightbearing pain in OA. We will use neurobiological techniques to study the anatomy and functional properties of this NP1 subset, and explore whether manipulating them can effectively and safely treat OA pain.